ECOG-ACRIN Network Group Statistics and Data Management Center

This grant will provide support for the Statistics and Data Management Center (SDMC) of the ECOG-
ACRIN Cancer Research Group. The SDMC is organized and operated jointly by the Department of
Biostatistics and Computational Biology at the Dana-Farber Cancer Institute (DFCI), the Department of
Biostatistics at Brown University, the ECOG-ACRIN Medical Research Foundation (EAMRF), and the
American College of Radiology (ACR), under the direction of the Group Statisticians. The primary
responsibility for data collection and management belongs to the Data Management Center, consisting
of EAMRF and ACR. The primary responsibility for study design, monitoring, and analysis, and for
overseeing and coordinating SDMC operations, belongs to the Biostatistics Center, consisting of DFCI
and Brown University. The primary contact site for grant administration is DFCI. ECOG-ACRIN is a
multi-modality group conducting a wide range of studies, including definitive phase III trials of
therapeutic interventions, earlier phase studies developing new therapies, studies focused on diagnosis
and of advanced imaging methods, investigation of laboratory and imaging based biomarkers, and
studies incorporating patient reported outcomes. The SDMC is responsible for all quantitative aspects
of EA's activities. Our overall goals are to conduct clinical trials to the highest standards in statistical
methods, data management, and regulatory compliance, while continually improving efficiency of all of
our processes and systems to optimize the use of our limited resources. Areas of particular focus in
this grant include studies incorporating tissue and imaging biomarkers to direct therapy, studies of
immunotherapy, studies of de-intensification of therapy to reduce morbidity, studies investigating novel
biomarkers, and studies investigating the relationship of biomarkers and therapy in populations defined
by race, ethnicity, gender, and age.

Public health relevance
The overall purpose of this grant is to provide expertise in statistics and data management to support the research mission of the ECOG-ACRIN Cancer Research Group. Achievement of our objectives will enable ECOG-ACRIN to continue to produce high quality clinical studies that advance the care of cancer patients.